Administrative Core

REVISED ABSTRACT:

Project Summary – Administrative Core (AC) The role of the Administrative Core (AC) of the Indiana Alzheimer Disease Research Center (IADRC) is to provide strategic planning, management, resources, and oversight for the Center in support of its continued mission. The significance of this role is based on the U.S. National Plan for AD (NAPA), to prevent and effectively treat AD by 2025 through innovative research on etiology, early detection, and therapeutics. To help accomplish these goals the IADRC has proposed four Overall center aims for the IADRC renewal application: (1) Support, enhance, and expand innovative research on AD and related dementias targeting pathogenesis, diagnosis, treatment, and prevention; (2) Provide critical research resources and infrastructure to support existing studies and enable new innovative research, including a well-characterized longitudinally followed cohort of research participants; (3) Strongly support local, regional, and national/international dementia research collaborations to further the goals of the NIA, national ADRC Network, NAPA and related federal priorities; and, (4) Provide educational and training opportunities related to ADRD for learners of all levels. The AC is responsible for overall management and strategic direction of the IADRC. Leadership within the Center and AC has been stable, with Dr. Andrew Saykin serving as the Center Director since 2013. Brad Glazier has long served as IADRC Administrator and Sarah Van Heiden is the new Research Operations Manager. The AC has six specific aims: (1) Overall direction and strategic planning for research on AD and related disorders. The AC will help to leverage existing strengths of programs and faculty and develop new opportunities for scientific growth and impact. It will also foster integration among the cores for thematic cohesion. The AC will coordinate the Executive Committee, including key leaders to advise and help implement the Center goals. (2) Provide administrative support, resource management and oversight functions. (3) Ensure ongoing evaluation and oversight of scientific progress, research and training. (4) Advance the IADRC goals of fostering and expanding innovative research, training and collaborative academic activities related to AD/ADRD. (5) Develop and manage the IADRC Developmental Projects Program, including solicitation of proposals, a robust and impartial review process, and tracking outcome metrics based on external funding and publication; and (6) Serving as an effective interface to important external organizations and promoting collaboration with other regional, national and international AD research initiatives. This includes interaction with the NIA as well as the NACC, NCRAD, ADNI, DIAN, LEADS, ACTC, ADGC/ADSP, AMP-AD, ADMC/ADMP, MODEL-AD, TREAT-AD and other consortia. The IADRC is committed to accomplishing these aims to support and accelerate progress in addressing the challenges of AD and related disorders.